Developing and Piloting a School Staff-Based Intervention to Reduce Alcohol and Drug Use Among Sexual Minority Youth

PROJECT SUMMARY/ABSTRACT
Alcohol and drug use (e.g., tobacco and marijuana use) are major public health problems affecting large
proportions of youth. Alcohol and drug use also disproportionately burden certain youth populations, such as
sexual minority youth (SMY; i.e., adolescents who identify as gay/lesbian or bisexual, or who have same-
gender sexual behaviors or attractions). Compared with heterosexual youth, SMY have up to 600% higher
odds of lifetime drug and alcohol use. Despite these substantial disparities, few evidence-based interventions
exist for reducing alcohol and drug use among SMY. Nevertheless, SMY who report having supportive adults
at school, greater school connectedness, and lower bullying victimization have lower drug and alcohol use.
Therefore, an intervention that trains school staff (e.g., teachers, principals, nurses, counselors) to better
understand SMY, support SMY, and engage in positive bystander behaviors that protect SMY from bullying
victimization may reduce sexual-orientation disparities in drug and alcohol use. Furthermore, many school staff
desire to support SMY, but they report a lack of training as their primary impediment. To address these gaps, I
will execute two Specific Aims. In Aim #1, I will develop an online e-learning intervention aimed at improving
school staff’s knowledge, skills, and self-efficacy for supporting SMY. Using the intervention mapping
approach, I will develop, user-test, and refine intervention materials by: conducting focus groups with a School
Staff Advisory Board; performing usability tests via think aloud interviews with school staff; and collaborating
with professional e-learning developers. In Aim #2, I will pilot test the feasibility and preliminary efficacy of this
school staff-based intervention using a two-armed cluster-randomized controlled trial. I will enroll high schools
participating in the fully-funded survey infrastructure of the MetroWest Adolescent Health Survey (MWAHS),
located outside Boston, Massachusetts, where sexual-orientation disparities in drug and alcohol use still exist.
Biennially, the MWAHS administers surveys to all students in each school, providing ample student-level data.
In tandem, I will collect new longitudinal survey data (baseline and 6-month follow-up) from all school staff
within each enrolled school. This e-learning intervention is easily modifiable and economically scalable, making
it apt for wide dissemination with the potential for population-level impact in reducing drug and alcohol use
disparities. To successfully complete my research, I will acquire training in: (1) the development of stakeholder-
informed interventions, particularly e-learning programs; (2) implementation science research; and (3) the
design and analysis of experimental studies. Guided by a strong interdisciplinary mentorship team, my planned
training activities include mentorship meetings, formal coursework, training institutes, scientific seminars, and
research conferences. Upon successful completion of my research and training plans, I will be propelled
towards achieving my long-term goal, which is to become an independent scientific researcher specializing in
stakeholder-informed intervention science aimed at reducing drug and alcohol use disparities for SMY.

Public health relevance
PROJECT NARRATIVE The Institute of Medicine’s 2011 report titled “The Health of Lesbian, Gay, Bisexual, and Transgender (LGBT) People” calls for the development of evidence-based interventions for reducing sexual minority youth’s large and persistent disparities in drug and alcohol use. The goals of the proposed research are to develop and pilot test an e-learning intervention that trains school staff to better understand, support, and protect sexual minority youth, and this novel intervention is hypothesized to increase adult support and school connectedness and simultaneously decrease bullying victimization, drug use, and alcohol use among sexual minority youth. Given the dearth of published research on alcohol and drug use interventions for sexual minority youth, this project will provide novel scientific contributions that can help foster health equity for sexual minority youth.